IL2 RECEPTORS--MOLECULAR REGULATION

The human interleukin-2 receptor is being studied to understand critical components of the T cell immune response in normal and neoplastic cells. Following T-cell activation, IL-2 and IL-2 receptors are induced; the magnitude and duration of the T-cell immune response is controlled by the amount of IL-2 produced, the levels of receptors expressed, and the time course of these events. Three chains of the IL-2 receptor exist, IL-2Ralpha, IL-2Rbeta, and gamma-c, with IL-2Ralpha and IL- 2Rbeta being significantly regulated at the level of transcription. The laboratory has focused primarily on the types of signals induced by IL-2, particularly the activation of STAT proteins, and the mechanism of regulating IL-2Ralpha in response to mitogen and IL-2. The group previously identified two enhancer-like regions regulating the IL-2Ralpha gene, and shown that proteins binding to these regions could physically interact. A critical element binds the Ets family protein Elf-1, which associates with NF-kappaB p50, c-Rel, HMG-I(Y), and TFIIB. Based on a binding site selection analysis, it was reported that the optimal site for ElF-1 binding is to an A(A/t)(C/a)CCGGAAGT(A/S) motif, a motif which interestingly is not found in any Elf-1 regulated genes. Instead, Elf-1-regulated genes, including IL-2Ralpha gene, have lower affinity sites, thereby allowing efficient association of Elf-1 only in the context of accessory proteins, and allowing for finer regulation of these genes. Considerable progress has been made in analyzing the STAT proteins (signal transducers and activators of transcription) induced by IL-2. IL-2 can activate both Stat5a and Stat5b (two closely related proteins with>90% amino acid identity) in fresh peripheral blood lymphocytes (PBL) and additionally activates Stat3 in PBL preactivated with phytohemagglutinin. Both human Stat5a and Stat5b have been cloned and it was reported that the genes encoding these two proteins are located on chromosome 17. It was also reported that IL-2-induced Stat5a and Stat5b binding activity could be reconstituted COS-7 cells. Interestingly, however, IL-2-induced transcriptional activation of a Stat5-responsive reporter construct was not induced, suggesting that either a lineage-specific modification or accessory factor was required for activation. This system should prove valuable in clarifying what additional components are required for successful reconstitution. An IL-2 response element was also delineated in the 5' regulatory region of the IL-2Ralpha gene. This element contains binding sites for Stat5 as well as an Ets family protein and provides an understanding of how the IL-2Ralpha gene can be stimulated by antigen and mitogen (via the two enhancer-like element previously described) or by IL-2 (via a mechanism requiring this newly identified IL-2 response element). Thus, these studies provide a molecular basis for IL-2 upregulation of the IL-2Ralpha gene. We have produced Stat5a and Stat5b protein in baculovirus so that the requirements for binding and activation of these proteins can be studied with purified reagents, and have performed the yeast two hybrid analysis to identify factors that can interact with Stat5. Overall, these findings extend our understanding of IL-2 receptor gene regulation as well as other T-cell activation genes regulated Elf-1 and Stat5.